tRNA modifications regulating mitochondrial function and the mitochondrial proteome in AD/ADRD

Abstract
Mitochondrial (MT) function decreases with age, and its dysfunction contributes to the pathogenesis of
Alzheimer’s disease and related disorders (AD/ADRD). The 22 mitochondrial tRNAs (mt-tRNAs), with help from
nuclear-tRNAs, translate the 13 MT-encoded proteins, which are essential subunits of the respiratory chain
complexes responsible for ATP production. mt-tRNAs also contain post-transcriptional modifications catalyzed
by nuclear-encoded mt-tRNA-modifying enzymes. After transcription the many of the ~500 nuclear-encoded
tRNAs (nuclear-tRNA) with cytoplasmic modifications should impact MT function by influencing the translation
efficiency of nuclear-encoded MT proteins synthesized in the cytoplasm and then imported into the MT, which
is defined as the MT proteome and includes ~1,150 proteins encoded by both nuclear DNA (nDNA) and
mitochondrial DNA (mtDNA). In humans ~50 types of tRNA modifications occur on cytoplasmic and mt-tRNAs.
We found that mt-tRNA-modifying enzymes (e.g., TRMU, NSUN3, GTPBP3, PUS1) are upregulated in human
AD brains. An emerging area of interest is to investigate tRNA-based MT-nuclear crosstalk. Rigorous scientific
evidence also supports the idea that abnormal MT function linked to susceptible loci in mtDNA and nDNA
increases the likelihood of AD by changing the expression of tRNAs or modifications to perturb MT-nuclear
interactions in AD brain. We hypothesize that genetic mutation and aberrant modification of mt-tRNA and
nuclear-tRNA impair the bidirectional MT-nuclear crosstalk, to disrupt the translational efficiency of the
MT proteome. In this proposal, we will identify genetic mutations in mtDNA, tRNA genes, and genes encoding
the MT proteome associated with AD status using >100k multi-ancestry WGS data in the AD Sequencing Project
(ADSP), and AD-related multi-ancestry endophenotypes harmonized by the ADSP-PHC, and molecular
pathways in multi-ancestry multi-omics data in the AMP-AD and the ADSP-Functional Genomics Consortium
(ADSP-FGC) (Aim 1). Then we will identify AD-related tRNAs and modifications using our unique platforms of
AQRNA-seq that can profile tRNA abundance, and LC-MS that can profile 50 tRNA modifications from two
human AD brain regions to examine relatively region-specific and AD-related tRNA profiles, providing an
exceptional resource for studying tRNAs in ADRD (Aim 2). Finally, we will select the top tRNAs (~5) and tRNA-
modifying enzymes (2-5) for further functional evaluation with our 3D human assembloid model of ADRD, to
identify those tRNAs or tRNA modifications with the strongest effects on pathology or neurodegeneration and
thus uncover disease mechanisms or therapeutic targets for AD (Aim 3).

Public health relevance
Project Narrative The identification of dysregulated tRNA systems (tRNAs and their modifications) opens a new window into potential mechanisms of neurodegeneration in Alzheimer’s disease and related disorders (AD/ADRD). tRNA is an unexplored communication between mitochondria and nuclear protein synthesis, with nuelar encoded enzymes modifying mitochondrial encoded tRNAs (mt-tRNA). This proposal seeks to characterize the relationship between nuclear-tRNA and nuclear-encoded proteins, and determine how mt-tRNA and nuclear- tRNA and their tRNA modifications interact and influence ADRD neuropathology or neurodegeneration. Successful discovery of key genetic loci, tRNAs, or mt-tRNA/nuclear-tRNA interactions in human aging brains could uncover novel biomarkers, interactions, or disease mechanisms, thus providing new therapeutic targets for modulating mitochondrial function and ameliorating neuropathology in AD.